SPECT ACTIVATION IN MEMORY DISORDERED PATIENTS

Determine if the regional cerebral blood flow (rCBF) of patients with isolated amnestic syndromes differs from that of healthy persons, particularly during performance of memory tasks.